Assessing the burden of dementia in transgender populations

Project Summary
Building on research to assess risk factors for atherosclerotic cardiovascular disease (CVD) in transgender
populations, the proposed project uses methods validated in the parent grant to characterize dementia,
including Alzheimer’s Disease, in transgender populations. The project’s main aim will be to use a robust
method of identifying transgender individuals within claims data to assess rates of dementia diagnoses among
transgender persons compared to cisgender referents. Completing the proposed aims will 1) demonstrate the
utility of prior work by utilizing methods validated in the parent grant; 2) reveal further evidence in a unique
population of traditional risk factors for cardiovascular disease that are linked dementia; and 3) inform future
research into aging and dementia prevention in transgender populations. By engaging in mentored research
with Drs. Emelia Benjamin (Mentor), Michael Paasche-Orlow (Mentor), Howard Cabral (Mentor), and Sari
Reisner (Mentor), and collaborators, and participating in seminars, conferences, and regular mentoring
meetings, I will develop expertise in four new areas critical to my development as an independent clinician-
scientist evaluating health outcomes to characterize and mitigate CVD and dementia risks for transgender
individuals: 1) Quantitative methods to analyze claims-based & electronic health record data; 2) Quantitative
methods to assess prediction models; 3) Clinical skills in transgender endocrinology, cardiology, & preventive
care. Moreover, I will extend my grant writing and oral presentation skills by participating in grant writing
courses and presenting at research meetings and seminars. Boston University offers junior scholars with the
intellectual and practical resources they need to develop into successful independent investigators, including
junior faculty seminars, grant writing, editing, and review services, and opportunities for intellectual exchange
and collaboration with senior colleagues. An administrative supplement to my K01 award will provide me with
the research experience, skills, and mentorship I need to build a cutting-edge independent research program
that assesses and addresses cardiovascular health and its effects on additional outcomes such as dementia in
sexual and gender minorities, particularly transgender adults.

Public health relevance
Project Narrative Risk factors for heart attack and stroke are linked to dementia, including Alzheimer’s Disease. By using recently validated methods to identify transgender persons in existing data, this project will build on prior work assessing risk factors in transgender persons and characterize rates of dementia in this population.